FUNCTIONAL PROPERTIES OF HEMOGLOBINS AND MYOGLOBINS

Our long-range goals are to determine: (1) the number of discrete steps involved in ligand binding to mammalian myoglobins and hemoglobins; (2) the pathway for entry into and exit from the distal pocket in each heme protein; (3) the free energy contributions from amino acids located along this pathway to the observed kinetic barriers. The stereochemical restrictions and polarity of the distal pockets will be examined by measuring the functional effects of mutations at the His64(E7), Val68(E11), Phe43(CD1), Arg45- or Ly45(CD3), Leu29(B10), Ile107(G8), Leu32(B13), and Thr67(E10) positions in sperm whale and pig myoglobins and at the His(E7) and Val(E11) positions in the alpha and beta subunits of human hemoglobin. In the latter case, rate parameters will be assigned to the individual subunits within the R and T quaternary conformations in order to evaluate the structural and functional causes of altered ligand reactivity in tetrameric hemoglobin. Overall association and dissociation rate constants for O2, CO, NO, and alkyl isocyanides will be measured by conventional stopped-flow rapid mixing and photolysis methods; intramolecular geminate recombination reactions will be measured by nanosecond and picosecond laser photolysis techniques. The kinetic studies for hemoglobin will be supplemented with equilibrium measurements to determine as accurately as possible T-state and R-state affinity constants for native and mutant hemoglobin subunits and to check the equilibrium parameters calculated from the ratio of rate constants. When possible, similar equilibrium measurements will be made for ligand binding to myoglobin mutants. For selected protein-ligand complexes, kinetic and equilibrium measurements will be made as function of temperature and solvent viscosity to determine the enthalpic and entropic contributions of the free energy barriers and to estimate the magnitude of molecular motions involved in the various kinetic processes. These functional studies will be correlated with structural results obtained by X-ray crystallography and NMR and EPR spectroscopy for the same set of mutants. This combined structural and functional approach will provide a unique and comprehensive data set for evaluating molecular dynamics models and for designing heme protein blood substitutes with optimized O2 transport properties and stabilities.